Gestational and Childhood Exposure to Endocrine Disruptors: Epigenetic and Proteomic Pathways to Adolescent Neurobehavior

PROJECT ABSTRACT
Endocrine-disrupting chemicals (EDCs) are man-made exogenous compounds that are widely used in
materials that humans interact with on a daily basis (food, consumer products, household materials). Exposure
to these chemicals among the US general population was found to be prevalent. EDCs mimic natural
hormones, interact with several nuclear receptors, and alter epigenetic programming and signal transduction
mechanisms that are linked with adverse neurodevelopment. Understanding the underlying endocrine-
disrupting mechanisms that contribute to neurobehavior and identifying critical windows of exposure is a critical
prerequisite for targeted interventions. Although EDCs were linked with neurodevelopment (including
neurobehavior), the underlying mechanisms are not fully understood. This proposal focuses on potentially
critical but under-explored endocrine-disrupting mechanisms linked with adolescent neurobehavior. Aim 1
(K99) will assess the associations between gestational exposure to EDCs [polybrominated diphenyl ethers
(PBDEs), organophosphate esters (OPEs), phthalate biomarkers] and cortical volume/thickness of the brain
among children at age 12 years, mediated by neuro-CpG methylation. Aim 2 (K99) will assess gestational
exposure to EDCs and neurobehavioral assessments among children at age 12 years, mediated by neuro-
CpG methylation. These aims will critically assess the joint associations between gestational EDC exposures
and structural/functional changes in the brain among children. Additionally, identifying potential epigenetic
pathways that are involved in these associations. Aim 3 (R00) will be focused on evaluating the joint
associations between repeated exposures to EDCs (measured during gestation and childhood up to 8 times)
and neuro-related protein biomarkers among children aged 12 years. Finally, Aim 4 (R00) will examine the
potential pathways between endocrine disruption (measured at gestation and childhood) and adolescent
neurobehavior linked via epigenetic, protein, and neuroimaging biomarkers. Together, these aims will identify
both the timing of vulnerability and the endocrine-disrupting mechanisms underlying adolescent
neurobehavioral outcomes, thus informing translational models for targeted interventions. The support of this
K99/R00 Pathway to Independence award will provide the applicant with the training necessary to achieve
these aims, including training in molecular epidemiology, advanced statistical methods (high-dimensional
mediation, causal mediation, repeated exposures joint association methods, and multi-omics analysis), and
quantitative magnetic resonance imaging. These training objectives will be accomplished with the support of an
outstanding mentorship team, Drs. Chen, Braun, Schisterman, Cecil, Zheng, Li, Brunst, and the outstanding
technical and intellectual resources of the University of Pennsylvania. Together, the proposed scientific aims
and training objectives will form the foundation for an independent research program aimed at uncovering
potential endocrine disruption mechanisms linked with adolescent neurobehavior.

Public health relevance
PROJECT NARRATIVE EDCs are known to interact with several cellular processes and are linked with adverse neurodevelopmental outcomes. The findings of this study will uncover potential biological pathways that link endocrine disruption and adolescent neurobehavior. These advancements will benefit public health and minimize the burden of neurodevelopment on society by supporting environmental policy change and health literacy.